Administrative Core

Realizing Accelerated Progress, Investigation, Implementation, and Dissemination
in Learning Health Systems (RAPID-LHS) Administrative Core
The Administrative Core will provide operational support to the RAPID-LHS Center. This will include
administrative oversight of all activities, communication with AHRQ and PCORI, identification and engagement
of health systems stakeholders, robust health systems participation, program evaluation, and coordination of
dissemination. The Administrative Core will build and sustain the RAPID-LHS Center administrative operational
structure, Advisory Committee, and multi-level communication. The Administrative Core will comprise
Vanderbilt University Medical Center and Meharry leaders (Roumie, Rothman, Embí and Singh) with extensive
experience, who will be supported by experts, mentors, resources, and services in learning health system
science, biomedical informatics, patient-centered outcomes research, community engagement, health equity,
and health system operations. The Administrative Core will engage partner institutions to identify LHS
scientists and embed projects in real-world health care settings. Together, the leadership team at Vanderbilt
University Medical Center and Meharry Medical College will work with partners at Vanderbilt University, the
Vanderbilt Health Affiliated Network, the Veterans Administration, Nashville General Hospital, community
hospitals and clinics, and collaborations across the STAR Clinical Research Network to ensure that the
RAPID-LHS Center is successful in improving individual and population health, reducing health inequities, and
training scientists to lead LHS evaluations. The Administrative Core will follow a logic model to evaluate
program success using continuous quality improvement. We will incorporate process and outcome metrics to
enhance program performance. Based on our logic model, we will use benchmarks to examine and track the
RAPID-LHS Center’s effectiveness longitudinally over a 5-year to 10-year horizon. Assessments will include
the following categories:
• Scientist metrics: learning health system competency self-assessment, satisfaction with mentor
relationships and overall training, manuscripts published, grants submitted/funded, and use of career
development resources.
• RDAC metrics: number and type of Research Data Analysis Core (RDAC) components each scientist uses
annually, project outcome evaluation, and lessons learned.
• Person/patient-centeredness metrics: stakeholder engagement (both quantity of patient/family stakeholders
engaged and quality of engagement), assessment of person-centeredness of research.
• Population health metrics: impact on health equity and population health, including generation of real-world
evidence, improvements implemented into practice, and policy changes proposed to impact population.